An Innovative, Interactive, Model-Driven Serious Game for Health Literacy Engagement and Education

Project Summary/Abstract
Proposed is an innovative game-based system that provides model-driven, interactive, and engaging health
literacy education. It will aid in educating and increasing exposure to health literacy concepts and knowledge.
Significance: Modern healthcare makes complex demands on health consumers. As self-management of
healthcare increases, individuals have assumed more complicated roles in seeking information, understanding
rights and responsibilities, and making health decisions for themselves and others. Underlying these demands
are assumptions about people's knowledge and skills, that is their health literacy. Unfortunately, the U.S. has a
well-documented and concerning health literacy problem. Health literacy is well-established as a modifiable
factor that contributes to the promotion and maintenance of good health and wellbeing across the life course.
Hypothesis: We hypothesize our product will improve health literacy comprehension in a manner that general
audiences find accessible, intriguing, and enjoyable and in a way that is innovatively adaptable to continued,
real-world modeling and science provided health agencies. Our Phase I Specific Aims Are: 1) Establish
game design and user requirements with an expert panel, 2) Create a proof-of-concept game prototype, 3)
Evaluate system with a pilot study of end-users

Public health relevance
Project Narrative Communicating medical information to lay audiences is notoriously difficult. Historically efforts to address health literacy focused on providing educational materials and counseling in hospital/care provider settings. Because health literacy effects outcomes across the care continuum, including prevention, acute illness, and chronic disease management, more recently a focus has been placed on improving health literacy engagement through schools and by community organizations thereby promoting health literacy where people live – outside of clinical settings.